Myocardial Physiology of Growth Differentiation Factor Signaling

SUMMARY: Myocardial Physiology of Growth Differentiation Factor Signaling
GDF11 and the closely related protein GDF8 (also known as myostatin) can regulate cardiac
hypertrophy. We now have new prospective data in a large cohort of coronary heart disease patients showing
that low blood levels of subforms of GDF8 and GDF11 powerfully predict future all-cause mortality. These new
data point to specific forms of GDF11 and GDF8 as critical factors in heart disease. Furthermore, human loss-
of-function mutations in GDF11 have now been identified that cause multi-system disease, including
cardiovascular disease, showing the importance of GDF11 in human biology. GDF11 and GDF8 are members
of the transforming growth factor β (TGFβ) superfamily of extracellular ligands and were initially thought to
serve similar or redundant roles due to protein sequence identity (90% identical) within their mature signaling
domains. We recently collaborated with multiple other laboratories to determine that mature GDF11 is a
significantly more potent activator of SMAD2/3 dependent signaling than GDF8 in vitro, likely due to better
utilization of key signaling receptors. Moreover, through x-ray crystallography-guided biochemical experiments,
we identified key amino acids of the two ligands responsible for their differences in potency. These findings
support the concept that GDF11 and GDF8 are likely not functionally equivalent, especially when ligand
concentrations are low, as exist in vivo. However, it is not yet understood if differences in GDF11 and
GDF8 at the molecular level translate to distinct functional outcomes and pathway activation in vivo.
Defining the roles of these ligands in vivo can best be addressed by genetically engineered mice. Using
CRISPR technology, we have now generated three new lines of mice with specific changes guided by our
structural and biochemical studies on GDF11 vs. GDF8 to address this Project’s three Aims. This project will
uncover the biochemistry of these ligands in vivo while retaining regulatory structure of the endogenous
genomic loci. Importantly, we have already used Targeted Locus Amplification to prove that we have edited
only the intended amino acids in all three of the new lines of mice. Using these newly generated mice, we will
pursue the following Aims:
Aim 1. To test the hypothesis that introducing the mature domain of GDF11 into the myostatin (GDF8)
locus regulates cardiac size and function using Gdf8Gdf11swap mice.
Aim 2. To test the hypothesis that gain of potency in GDF8 with two specific amino acids from GDF11
regulates cardiac muscle growth in mice (Gdf8G89D/E91Q mice).
Aim 3. To test the hypothesis that GDF11 potency is required to maintain cardiac muscle function in
vivo under pressure overload using chimeric mice with specific amino acids from GDF8 introduced into mature
GDF11 (Gdf11D89G/Q91E mice).

Public health relevance
Aging of the heart is a major health care concern for Americans. This project studies the effects of specific proteins that can regulate cellular growth in the heart and aims to understand molecular mechanisms of these proteins.